Vanderbilt Diabetes Research and Training Center

Center Overview: Project Summary/Abstract The Vanderbilt Diabetes Research and Training Center (VDRTC), in its 43rd continuous year of operation as a NIH-sponsored Diabetes Center, seeks to continue its efforts to facilitate the discovery, application, and translation of scientific knowledge to improve the care of patients with diabetes. The VDRTC is an interdisciplinary program involving 121 participating faculty distributed among 15 departments in two schools and three colleges at Vanderbilt and neighboring Meharry Medical College. The VDRTC consists of: 1) Administrative Component that coordinates the scientific, organizational, and outreach activities; 2) Biomedical Research Component that recruits and selects VDRTC-affiliated investigators and supervises the research cores that facilitate and enhance their research; 3) Pilot and Feasibility Program that facilitates the development of new investigators into independent scientists and encourages scientists in other fields to enter the field of diabetes research; and 4) Enrichment, Training, and Outreach Program that fosters an environment conducive to collaborative, interdisciplinary research (seminar series, Diabetes Research Day), and to training new diabetes scientists. The VDRTC oversees three NIDDK-funded diabetes-related training programs and also serves as the coordinating and organizing center for the NIDDK Medical Student Research Program which has allowed more than 550 medical students from more than 100 US medical schools to conduct diabetes-related research at one of 15 NIH-supported Diabetes Research Centers. NIH support for the VDRTC is greatly amplified by: 1) Vanderbilt's sustained commitment to provide research space and additional financial resources; 2) a diverse, comprehensive array of research core services at Vanderbilt, which allows NIH funds to target unique, diabetes-related research cores; and 3) collaborative efforts with other NIH-funded research centers at Vanderbilt. The VDRTC is evolving and dynamic, including additions to its investigator base, expansion of VDRTC research areas, expanded focus on clinical and translational research, realignment and evolution of core support to provide unique, indispensable core services, and service as a regional and national resource for the diabetes research community. Because of the VDRTC and the environment it creates, VDRTC-affiliated investigators have made important scientific contributions related to diabetes, obesity, and metabolism.

Public health relevance
Center Overview: Project Narrative The Vanderbilt Diabetes Research and Training Center is working to understand why diabetes develops, how it can be prevented, and how diabetes treatment can be improved.